RFA-CE20-001 Supplemental Research to Enhance Engagement & Measurement with Communities Disproportionately Affected by Sexual Violence

Project Summary/Abstract
Sexual violence (SV) is a widespread and serious public health problem. Youth and young adults are
disproportionately affected, particularly on college and university campuses. Because SV confers negative
health, educational and social impacts across the lifespan, evidence-based primary prevention efforts are
critical. Our stakeholders have identified Hot Spot Mapping (HSM) as an emergent strategy to address the
physical and social context of SV through monitoring and characterizing unsafe areas in order to focus
targeted resources on safety improvements. While HSM is gaining popularity on college and university
campuses, the evidence base is limited. Neither the Theory of Change nor appropriate measures have been
tailored to the campus environment. Our study will conduct these essential formative steps in order to develop
and implement a rigorous trial to evaluate the impact of HSM on sexual violence prevention. The study goals
are to 1) characterize HSM implementation and evaluation capacity, 2) conduct formative research steps to
refine theory of change, identify appropriate measures, and leverage existing data for monitoring and
evaluation, and 3) conduct a pilot of measures and data collection procedures. These formative steps will
inform a subsequent protocol for a rigorous trial of this approach within higher education institutions in Aim 4.
Our study is innovative in its focus on institutional readiness as it relates to HSM implementation and
outcomes, and its use of ecological momentary assessment (EMA) in characterizing situational safety. We
leverage a robust and long-standing academic-practitioner team with extensive expertise in the design,
implementation and evaluation of sexual violence prevention programs. Results will generate victim- and
evidence-informed recommendations for meaningful, rigorous evaluation research to extend the evidence base
on sexual violence prevention in the uniquely relevant environment of higher education.

Public health relevance
Project Narrative The study advances the national priorities of identifying evidence-based primary prevention strategies for the pervasive problem of sexual violence among youth. Findings will advance the science on monitoring and evaluation strategies for emergent interventions that seek to create protective environments. Findings address a priority topic in health promotion and injury prevention in a population of high need.